CH/BIDMC/Harvard Medical School Neurology Resident Research Education Program

Project Summary
This competing continuation proposal will provide an opportunity for selected residents in the neurology
residency training programs of the Beth Israel Deaconess Medical Center (BIDMC) and Boston Children's
Hospital (BCH) to participate for 6 to 36 months in an intensive, mentored, research educational experience
during the final year of residency and subsequent fellowship years. This training will be designed to prepare
participating residents for successful competition for NIH funded independent mentored research awards, and
will facilitate the transition from resident/fellow to clinician-scientist. Each participant will work with one of 57
mentors, who have been recruited from the faculties of BCH, BIDMC, and Harvard Medical School (HMS). All
have active NIH funding and a history of training clinician-scientists. The proposed mentors cover all major
areas of the clinical and basic neurosciences, and include 30 investigators from BCH, 15 investigators from
BIDMC, seven investigators from HMS and five investigators from other Harvard and Harvard Hospital
affiliates. Thirty of these investigators are engaged in clinical/translational neuroscience research and forty-two
are engaged in basic neuroscience research. Mentors have been drawn not only from the Departments of
Neurology/Neurobiology, but also from Divisions/Departments of Anaesthesia, Cell Biology, Genetics,
Neurosurgery, Ophthalmology, Pathology, Radiology, Developmental Medicine, and Psychiatry. Selected
resident participants will learn state-of-the-art laboratory skills and will acquire the critical expertise necessary
for the conduct of responsible research. Data collected and analyzed will serve for publications as well as for
future NIH proposals. The program will be governed by a Steering Committee consisting of the PD/PIs, the
Department Chairs, and the Residency Directors of the participating residency programs. This Committee will
work together to recruit and select trainees, to monitor their progress, and to evaluate the effectiveness of the
training experience.

Public health relevance
Narrative Our R25 program seeks to prepare physicians for independent and competitive research by developing researchers who can combine the clinical expertise obtained during residency with a well developed and focused investigative research program. The CHB/BIDMC residency program combines both adult and child neurology within an environment that has great breadth and depth in basic and clinical neuroscience. Mentors chosen for the R25 include leading NIH funded basic cellular and molecular neuroscientists, as well as successful physician scientists actively engaged in clinical and basic neuroscience and experienced in, and eager to train physician scientists.